Incorporating Biomarkers of Prognosis and Cardiovascular Disease Risk in the Fit2Thrive Physical Activity Promotion Intervention for Breast Cancer Survivors

PROJECT SUMMARY/ABSTRACT Higher physical activity (PA) is associated with reduced risk of breast cancer (BC) recurrence and progression and increased survival. Increased PA is also associated with reductions in cardiovascular disease (CVD) mortality, the leading cause of non-cancer mortality among BC survivors (BCS). PA may prevent BC progression and CVD via its effects on inflammation and also decrease CVD risk via effects on cardiometabolic biomarkers. However, the exact biologic mechanisms are poorly understood as few PA interventions include biomarkers of BC progression or CVD risk. Additionally, most PA interventions are costly, intense, on-site multicomponent interventions that provide little insight into what components (i.e. phone calls, Fitbits, etc.) are, or are not, effective, and traditional venous blood sample collection is often costly and requires lab visits limiting the potential public health impact of this research. In order to increase

Public health relevance
PROJECT NARRATIVE The public health significance of this study lies in its potential to develop an improved understanding of how different physical activity intervention components influence biomarkers of disease progression and cardiovascular disease risk among breast cancer survivors. Findings could result in more feasible, effective, and scalable interventions for this population, and, ultimately, have the potential to improve cancer prognosis, delay cardiovascular disease onset and reduce cancer and cardiovascular disease mortality in breast cancer survivors.